Education and the Life-Course Pathways of Cognitive Impairment, Dementia, and Cognitive Decline in the United States and Mexico

PROJECT SUMMARY
The purpose of the proposed research is to describe and cross-nationally compare the life-course
pathways affecting cognition, cognitive impairment, dementia, and cognitive decline in the United States and
Mexico. The PI, Dr. Joseph Saenz, received his Ph.D. in Population Health Science at the University of Texas
Medical Branch where he received training in epidemiology and epidemiologic methods. Dr. Saenz has
extensive experience studying health disparities in Mexico and the Mexican origin population in the United
States. Joseph is currently a postdoctoral fellow at the Davis School of Gerontology at the University of
Southern California (USC) where he has begun to study cognition in these populations. The proposed training
will enhance the PI’s understanding of the measurement of cognition, and expose him to the approaches to
cognitive aging used across various academic disciplines including demography, psychology,
neuropsychology, and biology. Education is a strong predictor of cognitive function, cognitive impairment
without dementia (CIND), and dementia in late life. Education may affect the clinical manifestation of cognitive
functioning directly by impacting the strength and structure of brain structures and by providing greater
cognitive reserve to compensate for pathological changes in the brain. However, education may also affect
cognition via indirect pathways including occupation, income, wealth, healthcare access, and chronic
conditions. Understanding these pathways is highly significant given the aging of the U.S. and Mexican
populations and the social and economic costs of cognitive impairment. Because aging is a life-course process
that occurs within larger contexts, it is important to consider how larger demographic, economic, and political
contexts across countries influence cognitive development and decline throughout the life-course. Further, by
acknowledging these differing contexts, future work may design and implement cognitive interventions that are
more precisely catered to the context in which they are applied. These results also shed light on differences in
cognitive aging across developing and developed countries. While studies of aging in Mexico (Mexican Health
and Aging Study) and the U.S. (Health and Retirement Study) have used differing measures of cognitive
functioning and methods for measuring and classifying normal cognition, CIND, and dementia, the proposed
research makes use of newly collected harmonized assessments of cognitive functioning to develop
comparable measures of cognition and definitions of CIND and dementia. I will investigate the direct and
indirect pathways throughout the life-course through which education affects cognitive functioning, CIND,
dementia, and cognitive decline in late life using multinomial probit regression models, growth curve models,
and linear regression models to model CIND and dementia, cognitive decline, and cognitive function as a
function of variables spanning the life-course. USC is an ideal location to receive the training necessary for the
proposal given the multidisciplinary nature of the gerontology center, global study of aging, focus on cognition
and dementia, and availability of coursework and mentorship from leaders in demography, psychology, and
clinical psychology. This training will also position the PI to begin an independent research career and to
submit a successful R01 proposal in a faculty position.

Public health relevance
PROJECT NARRATIVE Education is strongly predictive of cognitive function and cognitive impairment in late life, the proposed research will cross-nationally examine the direct and indirect life-course pathways through which education influences cognition in late life in Mexico and the United States. These results will deepen our understanding of the role of education in cognitive function, and how larger demographic and social contexts may modify the pathogenesis of disease. Findings will suggest how, and at what stage of the life-course, societal resources should be allocated to be used most effectively.